Economic Evaluation of MEW Network Epilepsy Self-Management Programs

ABSTRACT: The Managing Epilepsy Well (MEW) Network has developed several epilepsy self-management
programs that have been shown to improve a range of health outcomes for people with epilepsy (PWE). Two
of these programs are UPLIFT (Using Practice and Learning to Increase Favorable Thoughts), which focuses
on depressive symptoms, and PACES (Program of Active Consumer Engagement in Self-Management in
Epilepsy), which targets epilepsy self-management more broadly. In prior and current funding cycles, the NYU
MEW Network Collaborating Center adapted UPLIFT for Hispanic PWE, evaluated the adapted program, and
is currently conducting a replication trial in a diverse sample of PWE.
UPLIFT and PACES are prime candidates for widespread dissemination given their efficacy, scalability,
availability in English and Spanish, and implementation structure (e.g., national facilitator training and technical
assistance programs). Implementation of UPLIFT and PACES in healthcare and community settings is ongoing
but remains limited by the lack of discrete, sustainable funding models. To facilitate program adoption and
maintenance, key questions related to costs and cost-effectiveness of the programs must be addressed.
We propose to conduct economic evaluations of UPLIFT and PACES that will generate critical data to enhance
adoption in clinical and community settings, and help identify strategies for reimbursement. We will analyze
data from completed and ongoing RCTs testing these programs; collect surveys from the large national pool of
trained UPLIFT and PACES implementers; and conduct prospective studies of UPLIFT and PACES in both
healthcare and community-based settings in New York. PWE will be enrolled from epilepsy clinics at NYU
Langone (Manhattan and Brooklyn) and from the Epilepsy Alliance of West Central New York. Guided by Gold
et al.’s (2022) model of measuring cost data in implementation science, we will assess implementation,
intervention, and downstream costs for the proposed economic evaluations. We will form an Advisory Board
comprised of clinicians, administrators, community partners, implementation scientists, and program facilitators
to ensure that all data needed to inform future decision making are collected. Our specific aims are to (1)
Implement UPLIFT and PACES in healthcare and community-based settings; (2) Measure implementation,
intervention and downstream costs of the two programs; (3) Conduct economic evaluations of UPLIFT and
PACES; and (4) Continue and expand collaborations with other MEW Network centers.
Our multi-pronged approach will allow us to evaluate the costs of implementing UPLIFT and PACES in both
clinical and community settings, with diverse patients (including Spanish speakers), and with different facilitator
types in order to better understand costs associated with these variations. By generating data on costs and
cost-effectiveness of UPLIFT and PACES, we will provide critical evidence to inform strategies to enhance
their adoption and sustainability, ultimately leading to improved health and quality of life among diverse PWE.

Public health relevance
PROJECT NARRATIVE UPLIFT and PACES are two evidence-based epilepsy self-management programs whose adoption and impact is limited by the lack of sustainable funding models. We propose an economic evaluation of these programs that will utilize data from completed, ongoing and new MEW Network trials in both healthcare and community settings, as well as surveys of trained program implementers across the country. By generating data on implementation costs and cost-effectiveness of UPLIFT and PACES, we will provide critical evidence to inform strategies to enhance their adoption and sustainability, ultimately leading to improved health and quality of life among diverse PWE.